Drug repositioning for Alzheimer's disease via genetics, electronic health records, and human iPSC models

Alzheimer's disease (AD) is a progressive neurodegenerative disease and the leading cause of
dementia in the United States. Unfortunately, there is no cure for AD. Drug discovery for AD has
suffered significant failures, many at late stage clinical trials, partly due to our poor
understanding of AD pathology and the lack of disease-relevant and human-relevant discovery and
development models. This calls for team efforts with diverse and complementary expertise to tackle
the challenges together, by developing innovative approaches from multiple angles to achieve the
goal of identifying AD drugs.

In this application, we propose three complementary Specific Aims that together aim to identify
FDA approved drugs with repurpose potential for AD, from distinct but complementary angles that act
synergistically to boost the likelihood of success. AD is a highly heritable disease, with an
estimated heritability of 70%, highlighting the critical role of genetics in understanding the
disease etiology. Recent genetic studies have identified over 30 loci, enabling us to dissect the
genetic architecture of AD, including the biological processes and cell types involved in disease
etiology. In particular, we aim to dissect the highly polygenic AD etiology into distinct
pathophysiological components to guide drug repurposing, which is only feasible in recent years
thanks to large scale GWAS and massive genomics data available publicly (Aim 1). In parallel, we
will mine millions of electronic health records (EHRs) to identify drugs that reduce AD risk and
cognitive decline, by developing phenotyping algorithms from EHR for AD related phenotypes (Aim 2).
In addition, we will develop a high­ throughput screening (HTS) gene expression profiling assay and
use human induced pluripotent stem cell (iPSC) models to identify candidate compounds, and will
further test the efficacy of the candidates in both patient-derived iPSC lines and AD mouse models
(Aim 3). The three aims are complementary and synergistic, in the sense that they independently
tackle the same problem from drastically distinct angles, while findings from one can be served as
validation for others. Altogether, leveraging distinct and complementary expertise, we expect to
yield bona fide repurposable drugs for AD with orthogonal support.

Public health relevance
Project Narrative: Alzheimer’s disease (AD) is a progressive neurodegenerative disease and the leading cause of dementia in the United States. Unfortunately, there is no cure for AD, and drug discovery for AD has suffered significant failures. In this application we aim to identify and validate drugs that are approved for other diseases to treat AD, via genetics, electronic health records and human iPSC models.